Translational Research Center for Traumatic Brain Injury and Stress Disorders (TRACTS)

The Translational Research Center for TBI and Stress Disorders (TRACTS, funded initially in 2009), a VA
RR&D TBI National Network Research Center based at the VA Boston Healthcare System, with a network site
at the Michael E. DeBakey VA Medical Center, intends to continue its mission of conducting multidisciplinary,
clinical research aimed at providing a multimodal psychological, biological, and neurobiological
characterization of traumatic brain injury (TBI) and deployment related stress disorders, and to use this
understanding to improve treatment for Veterans in the post-9/11 era, and ultimately for the entire population
served by the VHA. Taking a lifespan developmental approach, our carefully characterized and curated cohort
will continue to provide a wealth of insight into the complex medical and psychological problems besetting the
veterans who have entrusted us with their care. We identify four primary areas of scientific focus for TRACTS
over the next funding cycle, 2024-2029. There are a number of new projects proposed within each focus area:
Focus Area 1: Deep phenotyping of deployment trauma and its functional consequences using symptom-
based clinical presentations, molecular, genetic, and neurobiological advances from TRACTS – understanding
longitudinal pathways and trajectories to predict outcome. This central focus around investigative studies
concerned with the diagnosis and characterization of TBI, particularly concussion or mTBI as it occurs in the
context of other common deployment related comorbidities, such as PTSD, will continue leveraging newly
available longitudinal data.
Focus Area 2: Molecular and neurobiological characterization of deployment related brain trauma
using neuroimaging has been a central focus of TRACTS from its inception. Over the last decade we have
developed increasingly sophisticated approaches to study how the central nervous system is impacted by TBI
and its deployment related comorbidities in veterans. In the next funding period, we will have access to a newly
purchased Prisma 3T scanner, which will largely be devoted to research at VA Boston, that will greatly
accelerate our ability to develop new techniques in both functional and structural neuroimaging (e.g., adapting
proton density scans to examine the details of limbic and brain stem circuits, co-registration of EEG and MRI
data, MR Spectography, etc.). We will also add more sophisticated approaches to the analysis of MRI based
data in relationship to genomic and phenomic data from the TRACTS Longitudinal Cohort (TLC).
Focus Area 3: We will continue to develop innovative rehabilitative strategies to alleviate the physical and
psychological symptoms of veterans and to gain a more thorough understanding of the mechanisms of
treatment effectiveness. Of paramount importance to the TRACTS mission is to utilize the knowledge that has
been gained from the TLC to create or adapt treatment models to better support veterans’ reintegration and
adjustment after military service and to improve their functional status in their life roles (e.g., vocational,
community, and social functioning).
Focus Area 4: TRACTS will continue its support of competitive, short-term (approximately one year) projects
available to both junior and senior VA investigators for the purpose of generating pilot data to seed applications
for VA and NIH program applications supporting innovative research across the above focus areas.
The successful continuation of the proposed areas of study in TRACTS will help fill critical gaps in our
understanding of mTBI and repetitive blast and blunt exposure, and their expression in the context of a
complex neurobiological system. Collectively, the information generated will help to maximize the
psychological and neurobiological health of veterans and provide an outstanding training ground for new
investigators.

Public health relevance
The years from 2001 to 2014, when the United States was engaged in military operations following the September 11th, 2001 terrorist attacks, were momentous in many ways. For the VHA in particular, the post- 9/11 conflicts in Iraq and Afghanistan produced a new generation of returning veterans with deeply complex and challenging mental and physical problems resulting from their combat experiences. Since its inception in 2009, TRACTS has collected a vast array of longitudinal data detailing the complexities of the mental, physical, and brain health of post-9/11 veterans. Our well characterized group of participants is projected to surpass 1000 individuals by 2024. This representative group has allowed us to study the intellectual, emotional, neural, and molecular correlates of brain injury and traumatic experiences, which will lead directly to improved treatment for post-9/11 veterans now and into the future as they age.